Multi-scale feedbacks for robust organ development

PROJECT SUMMARY
One of the hallmarks of successful embryonic development is the reproducible and robust
formation of organs with the right shape and size. Failures in organ morphogenesis can result in
developmental disorders, lifelong birth defects, and, in some cases, embryonic lethality and
miscarriage. To address how complex forms reproducibly arise from simple tissues, research
studies across species have provided a simple mechanistic framework, where genetic-information
patterns cellular mechanics to drive tissue morphogenesis. However, this simple framework,
where information flows hierarchically from genes to cells to tissues, fails to account for: (i)
biological noise causing variations in tissue patterns, (ii) multi-scale feedback interactions, and
(iii) guiding roles of tissue geometry. To address these outstanding challenges in organ
morphogenesis, we will utilize an exemplary organ common to all vertebrate organisms— the
semicircular canals of the inner ear, in an accessible genetic model system— the zebrafish. The
three canals are mutually orthogonal, and this precise angular architecture is required for
detecting head rotations and maintaining balance. The intricate morphology of the canals arises
from the topological remodeling of a simple embryonic tissue, making it one of the most
geometrically complex and accurate morphogenic processes amenable to study. To investigate
how canal morphogenesis achieves robustness, we will establish a new experimental paradigm
by leveraging high-resolution microscopy, single-cell transcriptomic data, statistical analysis,
genetic, physical, and biophysical perturbations, and predictive physical modelling. This paradigm
will be deployed to: (i) measure variations in tissue patterns and morphologies; (ii) add variations
to tissue patterns for dissecting out the respective contributions of genetically-encoded
instructions versus other regulatory mechanisms, and (iii) systematically investigate the physical
constraints from tissue geometry and feedbacks through mechano-transduction in “canalizing”
variations during development. These innovative, distinct yet complementary approaches will
deliver a new, integrative framework encapsulating reciprocal flow of information between
genetic-patterns, cell behaviors and tissue geometry for successful embryonic development. This
framework will be used to identify the etiology of developmental defects and disorders in vivo. By
revealing underlying causes for birth defects or miscarriages, our research may, in the long term,
also impact human healthcare.

Public health relevance
PROJECT NARRATIVE The research proposal will provide critical insights for how organs with the right shape form reproducibly during embryonic development, using an organ common to all vertebrate animals— the inner ear, in a tractable animal model— zebrafish. The fundamental principles revealed from this study will address: (1) what is the normal variability during embryonic development, (2) how much variability developing tissues can tolerate; and 3) how is variability resolved by tissue geometry and multi-scale feedbacks to robustly give rise to correct organ shape. The research will improve our understanding of successful embryonic development and provide mechanisms for developmental disorders to reveal underlying causes for birth defects.